Potassium Channels and Dendritic Function in Hippocampal Pyramidal Neurons

Kv4.2 is an activity-dependent Ube3A substrate and contributes to synaptic plasticity and cognitive flexibility in Angelman syndrome

Angelman syndrome (AS) is a severe neurodevelopmental disorder affecting 1 in 20,000 people, caused by loss of function of imprinted genes on chromosome 15q11–13 or mutations in Ube3A. Ube3A is expressed exclusively from the maternal allele in hippocampal neurons and cerebellar Purkinje cells. Loss of Ube3A function leads to accumulation of target proteins, disrupting neuronal function. A TAP-MS screen identified Ube3A as a Kv4.2 binding protein. Follow-up studies by Dr. Jiahua Hu confirmed activity-dependent Kv4.2–Ube3A interaction, showing Ube3A ubiquitinates Kv4.2 at residue K103, which is required for activity-induced Kv4.2 degradation.

In an AS mouse model, Kv4.2 protein levels and K+ currents are elevated in the hippocampus. Seizure-induced Kv4.2 degradation, which normally requires Ube3A, is absent in AS mice. Ube3A-mediated Kv4.2 ubiquitination is significantly reduced in AS hippocampi, further supporting the role of Ube3A in Kv4.2 degradation. Additionally, studies showed that seizure-induced Kv4.2 degradation occurs on DPP6-containing Kv4.2 complexes, requiring Kv4.2 phosphorylation at the T602/7 Pin1 site.
Patch clamp studies by Dr. Cole Malloy revealed deficits in mEPSC frequency and spike-timing-dependent LTP in AS mice, which were rescued by crossing AS mice with conditional Kv4.2 KO (Kv4.2cKO) mice. Behavioral tests showed that some locomotion, nesting, and learning impairments in AS mice were also partially rescued in AS/Kv4.2cKO mice. In learning and memory tests, AS mice showed impairments in initial learning and reversal learning in an operant reversal test. However, the deficits in AS mice in reversal learning can be rescued by DKO mice. These findings reveal a novel Ube3A downstream pathway regulating plasticity and cognitive behaviors, and provide potential targets for the treatment of AS.

Kv4.2 complex regulation and its role in cognitive flexibility

To address the role of the p38-Pin1-Kv4.2 pathway in neuronal excitability and circuit function, we developed a mutant knock-in mouse model with a Thr607 to Ala substitution at the activity-induced p38 phosphorylation site (T607 to A607; Kv4.2TA). We have found that Kv4.2TA mice exhibit normal initial learning and memory in the Morris Water Maze and Lever Press, two tests of hippocampal-dependent learning and memory. However, they exhibited better 'reversal' learning in both tests than did WT mice. This improvement in reversal learning is indicative of an enhancement in cognitive flexibility. Dr. Malloy is investigating the mechanisms behind enhanced cognitive flexibility in Kv4.2TA mice, the first mouse model with this phenotype. Focusing on synaptic differences between Kv4.2TA and WT mice, patch clamp electrophysiology in hippocampal CA1 pyramidal cells showed that Kv4.2TA mice have similar basal synaptic transmission and preserved long-term plasticity. However, they exhibited a significant enhancement in the reversal of spike-timing dependent long-term potentiation with low-frequency stimulation (LFS), suggesting a synapse state-dependent difference in synaptic plasticity due to altered Kv4.2 complex regulation.

Pharmacological manipulations during LFS revealed distinct mechanisms driving this metaplasticity. The NMDA antagonist 5-AP, which fully blocks depotentiation in WT mice, only partially blocks it (~40%) in Kv4.2TA mice, indicating an additional mechanism in Kv4.2TA mice. The hypothesis is that altered metabotropic glutamate receptor (mGluR) signaling, specifically mGluR5, underlies this enhancement. Co-application of the mGluR5 antagonist MTEP with 5-AP fully rescues the depotentiation in Kv4.2TA mice, bringing it to WT levels, while MTEP alone fully prevents depotentiation in Kv4.2TA mice and only partially affects WT mice. This suggests depotentiation in Kv4.2TA mice is primarily driven by mGluR5, while in WT mice, NMDA receptors are more dominant.

In summary, this study uncovers a novel metaplasticity mechanism in Kv4.2TA mice linked to cognitive flexibility, with implications for therapeutic strategies targeting neurodevelopmental disorders with cognitive flexibility impairments. It reveals a shift in the molecular drivers of depotentiation between Kv4.2TA and WT mice, likely due to impaired Kv4.2 complex trafficking during synaptic activity.

Interaction Between mGluR5 and Kv4.2

Our previous research identified metabotropic glutamate receptor 5 (mGluR5) within the Kv4.2 protein complex through tandem affinity purification-mass spectrometry (TAP-MS) analysis. Both mGluR5 and Kv4.2 are peri-synaptically localized. We hypothesized that mGluR5 traffics with Kv4.2 in response to neuronal activity. It is well-documented that co-expression with dipeptidyl peptidase-like protein 6 (DPP6) and Kv channel-interacting protein 2 (KChIP2) enhances Kv4.2 surface expression, which subsequently increases mGluR5 surface expression, suggesting a regulatory role of Kv4.2 on mGluR5 surface expression. To investigate internalization dynamics, we utilized a bungarotoxin (BTX) binding site-tagged Kv4.2 construct (BBS-Kv4.2) to label surface Kv4.2 in live HEK 293T cells co-transfected with hemagglutinin (HA)-tagged mGluR5. Under control conditions (4℃), both proteins were localized on the cell surface. Upon incubation at 37℃ to induce trafficking, internalized mGluR5 colocalized with Kv4.2, indicating potential co-trafficking of these proteins.

Behaviorally, Kv4.2TA mice demonstrated normal initial acquisition in the Morris water maze but exhibited improved reversal learning capabilities. In contrast, mGluR5 knockout (mGluR5KO) mice displayed impairments in both initial acquisition and reversal learning. Contextual fear conditioning and extinction tests further revealed that mGluR5KO mice had impaired extinction of contextual fear memory, which nullified the enhanced extinction observed in Kv4.2TA mice, underscoring the essential role of mGluR5 in cognitive flexibility. Together, results from our studies show a synaptic correlate that accompanies enhanced contextual inhibitory learning in the form of a unique metaplasticity in the hippocampus, which is driven by mGluR5 in association with the Kv4.2 multimolecular complex.

Preso1 Regulation of Kv4.2

Preso1 (also known as FRMPD4) is a multidomain post-synaptic scaffold protein highly expressed in the hippocampus. Mutations in the Preso1 gene are associated with intellectual disability and cognitive decline in Alzheimer's disease patients. Previous studies have shown that Preso1 acts as a scaffold for mGluRs, recruiting proline-directed kinases that modulate receptor interaction with the regulatory protein Homer. Our research identifies Preso1 as a regulator of Kv4.2 channels in the hippocampus.
Using a Preso1 knockout (KO) mouse model, we observed a significant ~30% reduction in A-type potassium current (IA) in CA1 pyramidal neurons, leading to increased somatic and dendritic excitability. This was evidenced by a higher neuronal firing frequency, a more hyperpolarized action potential threshold, greater action potential amplitude, lower rheobase, and shorter latency to fire an action potential.
Synaptic plasticity at hippocampal CA3-CA1 synapses was compromised, with notable deficits in both spike-timing-dependent long-term potentiation (LTP) and N-methyl-D-aspartate receptor (NMDAR)-dependent long-term depression (LTD). These findings highlight the critical role of Preso1 in maintaining hippocampal excitability and synaptic plasticity.

Behavioral assays revealed that Preso1KO mice had impaired contextual memory, reversal learning, and increased initial learning (potentially due to heightened motivation) in lever press tasks. Kainic acid-induced seizure assessments showed no differences in overall seizure scores.

DPP6 and Sleep/Epilepsy in Aging Mice

Our studies have demonstrated that aging DPP6 knockout (DPP6-KO) mice, a model related to Alzheimer's disease, exhibit circadian dysfunction and sleep disturbances. Using in vivo wireless implants to measure electroencephalogram (EEG), electromyogram (EMG), behavioral activity, and body temperature, we found that 12-month-old DPP6-KO mice had significantly reduced non-rapid eye movement (NREM) sleep and increased rapid eye movement (REM) sleep during the light-on phase, with heightened wake time.
Sleep quality analyses indicated increased counts and transition times between sleep stages, pointing to fragmented sleep patterns. Overexpression of DPP6 in aging mice improved NREM sleep and decreased wake time, stabilizing sleep architecture and reducing fragmentation.

In terms of seizure activity, 12-month-old DPP6-KO mice exhibited significant epileptiform spikes and higher seizure scores following pentylenetetrazol (PTZ) induction. Immunofluorescence studies revealed a reduction in parvalbumin-positive (PV+) interneurons and degradation of perineuronal nets (PNNs) in the hippocampus, suggesting these factors contribute to increased seizure susceptibility.

Overall, our findings indicate that DPP6 plays a crucial role in regulating sleep and seizure susceptibility in aging mice, with potential therapeutic implications for Alzheimer's disease and epilepsy management.